Change-sensitive Measurement of Adult Functional Outcomes in Developmental Disabilities

7. PROJECT SUMMARY/ABSTRACT
Developmental disabilities (DD), including autism spectrum disorder (ASD), Down syndrome, Fragile X
syndrome, and other intellectual and developmental disabilities are heterogeneous neurodevelopmental
disorders that place considerable burden on individuals, families, and society. Although most research on DD
has focused on children, these conditions are life-long with few established treatments to support functioning in
adulthood. As a result, many adults with DD experience significant functional impairment represented by low
rates of employment, severe social dysfunction and isolation, and a limited ability to live independently and
experience autonomy in adult life. The development of interventions to improve adult functional outcomes in
social, employment, and independent living domains across DD has lagged far behind those developed for
children. A key factor limiting the development of treatments to improve adult functioning in DD is the lack of
validated assessments of functional outcome applicable to adulthood. Current studies either use measures
relevant to childhood with limited applicability to and treatment sensitivity in adults, or fail to assess this
important domain, greatly restricting knowledge on how adult functioning can be improved in DD. We have
shown in preliminary studies with adults with ASD that it is possible to develop measures of functional outcome
in adulthood that have greater validity and are more sensitive to treatment effects than existing measures
adapted from childhood. In response to this major gap in adult outcome measurement in DD and PAR-18-039,
“Outcome Measures for Use in Treatment Trials of Individuals with Intellectual and Developmental Disabilities”,
this project proposes to use NIH PROMIS methods to develop and validate proxy- and self-report versions of
the Adult Functioning Scale (AFS) for assessing functional outcomes in social, employment, and independent
living domains in adults with DD. A pool of potential items will be generated based on our conceptual model,
functional outcome measures used in other populations, and input from expert and stakeholder panels. This
item pool will then be completed by two calibration samples: Proxy reporters (e.g., parents, clinicians, group
home staff) for 1000 adults with DD representative of the full range of verbal and intellectual functioning in DD
and 1000 self-reporting adults with DD (N = 500 with ASD, N = 500 with other DD). Advanced psychometric
analytics employing exploratory and confirmatory factor analysis and item response theory models will be used
to create final calibrated item banks (and static short forms) of the AFS suitable for broad use in clinical trials
across heterogeneous DD. The reliability and validity of the AFS caregiver and self-report versions will be
examined in the calibration samples, along with a 4-week retest subsample (N = 200). Sensitivity to treatment-
related changes will be assessed in longitudinal intervention studies of inpatient and outpatient samples of
adults with DD. The results will validate the first measure of functional outcome for use in clinical trials in adult
DD and will pave the way for treatment advances to improve functioning in this underserved population.

Public health relevance
8. PROJECT NARRATIVE This project proposes to develop and validate the Adult Functioning Scale, a self- and caregiver-report assessment of social, employment, and independent living domains suitable for use in treatment trials for adults with developmental disabilities. The results from this project are of considerable public health significance in that they will establish a measure of functional outcome for adults with developmental disabilities that is broadly applicable across different conditions and severity spectra, and that can be used to monitor treatment changes in clinical trials seeking to improve functioning in adults with autism spectrum disorder and other developmental disabilities.